Coordination of innate and cellular mucosal immunity in SARS-CoV-2 clearance

SUMMARY
Neutralizing antibodies against SARS-CoV-2 are a strong correlate of protection against severe disease,
hospitalization, and death. However, a combination of waning immunity and evolution of immune-evasive
variants jeopardizes vaccine-mediated immunity. While there has been a strong research emphasis on humoral
immunity, we still have a limited understanding of how mucosal innate and T cell responses contribute to SARS-
CoV-2 viral control and clearance. The first few days of SARS-CoV-2 infection are marked by a transient antiviral
type I interferon (IFN) response and proinflammatory cytokine and chemokine induction concomitant with
mobilization of inflammatory CCR2-monocytes that traffic into the respiratory tract. Using C57BL/6 mice with a
naturally occurring pathogenic SARS-CoV-2 variant (B.1.351), we previously determined the importance of
CCR2- monocytes in mediating protective immunity against SARS-CoV-2. These innate immune responses are
followed by the development of virus-specific antibodies and T cell responses that mediate viral control and lead
to clearance. While these studies and many others have shown how aberrant immune responses at any of these
stages can lead to a defect in viral control and deleterious immunopathology, most have focused exclusively on
the lower respiratory tract , i.e. the lungs. In contrast, few studies have investigated the orchestration of immunity
in the upper respiratory tract (URT), the site of initial virus transmission and replication, and how the individual
components of the immune response contribute to viral control at this site. Here, we present evidence showing
that the contributions of monocytes and T cells in promoting viral control differ between the upper and lower
respiratory tract (LRT), as these responses were critical for clearance in the URT but not the LRT. We
demonstrate that MYD88 signaling and inflammatory monocytes are critical for controlling early viral replication
in the nasal cavity. We also found that while antigen-specific T cells infiltrate the both the nasal compartment
and lungs early during infection, T cells appear to contribute a minimal role in promoting viral control and
clearance in the lungs. In contrast, both CD4+ and CD8+ T cells in the nasal compartment are required for
preventing persistent and culturable virus replication within nasal epithelial cells. Based on our findings, we
hypothesize that the coordinated responses of inflammatory monocytes and virus-specific T cells in the upper
respiratory tract are necessary to limit early viral replication and prevent viral persistence at this site. In Aim 1
we will determine the contribution of monocytes in promoting T cell responses and viral control within the
respiratory tract. In Aim 2, we will define the effector mechanisms of protective mucosal T cell responses against
SARS-CoV-2 infection and persistence in the URT versus LRT. Both Aims will explore these questions in the
context of primary and vaccine breakthrough infections using our novel murine model of suboptimal versus
protective vaccination. Overall, these studies will advance our understanding of protective mucosal innate and
T cell responses that can leveraged for next-generation vaccines against SARS-CoV-2.

Public health relevance
NARRATIVE Infection with SARS-CoV-2 in humans has caused a pandemic of unprecedented dimensions and a combination of waning immunity and evolution of immune evasive variants continues to jeopardize vaccine-mediated immunity. Our studies are focused on understanding the coordination of monocytes and T cells within the upper and lower respiratory tract for limiting SARS-CoV-2 replication and viral persistence during primary and vaccine breakthrough infections. These studies will advance our understanding of mucosal innate and T cell responses that can leveraged for next-generation vaccines against SARS-CoV-2.